Investigating the molecular, cellular and circuit effects of transcranial magnetic stimulation

Abstract
Transcranial magnetic stimulation (TMS) is a non-invasive brain stimulation method which can alter brain
activity in humans in a safe manner. Due its ease of application and ability to target specific brain regions, the
repetitive application of TMS (rTMS) has the potential of augmenting or even replacing classic pharmacologic
treatment-strategies. However, due to the enormous parameter space concerning its application (amplitude,
coil position and orientation), optimal, i.e., personalized stimulation parameters for rTMS are very difficult to
determine. Most importantly, principled efforts for optimizing TMS stimulation parameters are seriously limited
by a poor understanding of molecular and cellular mechanisms. In-vitro recordings and functional optical
imaging in slice preparations allow a direct assessment of the interaction of TMS electric fields with neurons in
a highly controlled environment and allow for a rapid scan of stimulation parameters not achievable in human
studies. Non-human primate (NHP) models are ideally suited to study circuit effects of TMS due their similarity
to humans and the ability to perform invasive recordings to measure the electrophysiological response to TMS.
Computational models can predict the electric field distribution of TMS in neural tissue, allowing to couple the
biophysics of TMS with its physiological effects.
Here, we propose to study the effects of changing TMS parameters in detail using in-vitro slice preparation,
NHP recordings and computational modelling. We plan to study the molecular, cellular and circuit effects of
transcranial magnetic stimulation in three specific aims: 1.) Systematic study of TMS stimulation parameters
(stimulation intensity, coil orientation) in-vitro using mouse vs. rat hippocampal slices. 2) We will measure the
circuit effects of varying TMS parameters in a NHP model. 3) Computational modelling of TMS electric fields
across scales.
Our findings will form the foundation for a mechanistic understanding between the biophysics of TMS electric
fields and their physiological effects. This can form the basis for future efforts to improve noninvasive
stimulation technologies.

Public health relevance
Project Narrative: This research aims to study the molecular, cellular and circuit effects of transcranial magnetic stimulation. Our studies will form the foundation for a mechanistic understanding of TMS effects based on their underlying biophysics. Such advances are vital for advancing TMS as a therapeutic approach and the development of new brain stimulation methodologies.